Characterizing molecular interactomes using TurboID

During this period, the team has developed tools to explore new uses of TurboID as a proximity labeling tool to define interactomes.

This collaborative team aims build on previous extramural research that has developed a promiscuous biotin ligase TurboID. The Early Translation Branch's (ETB) overall goal is to uncover new small molecule probes and catalyze the process of therapeutic development through a model of collaborative research. With each collaboration, NIH and extramural disease experts work with the ETBs drug discovery teams, leveraging their expertise in small molecule screening, medicinal chemistry and informatics.